An On-line Family Intervention for Pediatric TBI

Moderate to severe traumatic brain injury (TBI) in children is a significant family stressor resulting in increased caregiver burden, impaired psychological adjustment among caregivers, and deteriorating family functioning. Empirically based interventions for families following TBI are virtually nonexistent, and access to skilled therapists may be restricted by distance and finances. The current project seeks to address these needs by developing and piloting an innovative on-line intervention for families of children with TBI. The intervention will be adapted for the World Wide Web from a recently developed program integrating an established problem-solving protocol with training in TBI- specific behavior management strategies. The proposed study will develop the on-line intervention materials and test them in a small randomized, controlled trial comparing the effects of standard care plus Internet access to standard care plus the on-line family intervention on the following outcomes: 1) problem-solving and communication skills; 2) injury-related stress and burden; 3) caregiver psychological distress; and 4) parent-child conflict. Participants will include the families of children, aged 6 - 14, who have experienced a moderate to severe TBI between 3 and 15 months prior to study participation. All families will be given a computer, modem, and Internet access to reliable brain injury information sites on the Web and randomly assigned to a treatment group. Group differences will be examined using a multivariate approach to analysis of covariance, controlling for injury severity, child's age, SES, and time since injury. We hypothesize better problem solving and communication skills, less injury-related stress, better caregiver functioning, and less parent-child conflict among the intervention group compared to the standard care group. This family-centered intervention program makes use of emerging technology to address the complex needs of families following TBI with the goal of reducing psychological distress in caregivers, thereby enabling the family to optimally support the child's recovery from TBI.